GENE REGULATION AND FUNCTION OF BASEMENT MEMBRANES

Basement membranes are thin extracellular matrices that form an interface between endothelial, epithelial, muscular, or neural cells and their adjacent stroma. Developmentally, basement membranes are the first extracellular matrix to appear and play a critical role in organogenesis. They not only support cells and cell layers, but they also have an essential role in tissue organization that affects cell adhesion, migration, proliferation, and differentiation. Additionally, basement membranes provide major barriers to invasion by metastatic tumor cells. Thickness and compositions of basement membranes are different in various tissues, suggesting tissue-specific functions. Basement membranes are degraded and regenerated during development and wound repair. The major molecules in basement membranes are collagen IV, laminin, perlecan, and nidogen/entactin. Recently, diversity has been discovered in the subunits that make up the trimers of collagen IV and laminin molecules. Our primary objectives have been to identify the specific functions of basement membrane components, to study the structure and function relationships, to elucidate the mechanisms by which they are regulated, and to describe related protein interactions in development and diseases. Our effort has also focused on establishing animal models to study functions of basement membrane components in development and disease and on creating therapeutic reagents for diseases associated with basement membranes. We have also identifying bioactive sites on laminin which has a number of biological activities such as promoting cell adhesion, migration, and neurite outgrowth, and affecting metastatic activity of tumor cells. These studies are aimed towards developing reagents useful for diagnostic and therapeutic applications. - Basement membrane, gene regulation, development